Next Generation Multi-modal Human Connectome Project Atlases

This project will develop three new multi-modal atlases based on high resolution Human Connectome Project
(HCP) data and its precise methods. 1) The project will create a new data-driven atlas of spatially overlapping
weighted grey-matter functional networks, side-stepping current limitations in non-weighted, non-overlapping
atlases of functional networks and compare to the prior literature. 2) The project will create a new data-driven
atlas of white matter tracts and their corresponding grey matter projection territories and compare these results
to traditional ROI-based atlases, which may have biases or have missed tracts. 3) The project will complete the
semi-automated multi-modal atlas of human brain areas, building upon the HCP’s prior map of 180 neocortical
brain areas per cerebral hemisphere to include the non-neocortical brain areas using surface-based and volume-
based methods as appropriate with extensive comparison to the prior neuroanatomical literature. The end result
of successful completion of this project will be complete, integrated atlases of human grey matter brain areas,
functional networks, and white matter tracts, which will have intrinsic value, e.g., for neurosurgical planning.
These atlases and the automated methods for regenerating them in new subjects will enable measuring multi-
modal imaging derived phenotypes (IDPs) for HCP-Style neuroimaging data across the whole brain. By collaps-
ing non-independent statistical tests within neuroanatomically well-defined brain structures and averaging out
random noise, such IDPs will have improved statistical sensitivity and power. This generically useful approach
has the most promise for creating interpretable imaging biomarkers useful for elucidating the mechanisms behind
both healthy brain aging and Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias (ADRD).
Each aim of the project will have a technology development sub-aim (part a) to develop or improve upon the
needed methods for generating that aim’s atlas. Then the atlas will be created using data from the young adult
HCP (part b) and the findings will be integrated across the 3 aims (i.e., direct comparison and cross-annotation
between the atlases of brain areas, grey matter functional networks, and white matter tracts). Finally, we will
produce automated pipelines to regenerate the atlases in the data of the HCP Aging project, the Adult Aging
Brain Connectome (AABC) project, and the Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Demen-
tias (ADRD) Connectomes Related to Human Disease (CRHD) projects, to disaggregate the data by sex, and to
generate multi-modal IDPs based on these atlases, pipelines that external investigators can also use in their
own studies. These atlases and IDPs will then feed into five ongoing projects studying Alzheimer’s Disease (AD)
and Alzheimer’s Disease Related Dementias (ADRD), four that are subprojects of the AABC and an R01 that is
working on the AD/ADRD CRHD data. Overall, the proposal will address three key gaps in the current HCP
atlases and IDP generation pipelines to accelerate innovation and discovery in the neuroimaging field.

Public health relevance
The overall goal of this project is to generate new multi-modal brain atlases using high-resolution Human Con- nectome Project (HCP) data, and precise methods that can regenerate these atlases in new data using auto- mated software analysis pipelines. These atlases, in addition to having intrinsic value in, for example neurosur- gical planning, can then be used to subdivide the brain into neuroanatomically sensible units such as brain ar- eas, grey matter functional networks, and white matter tracts, allowing multiple non-invasive imaging modalities to be measured within these units at greater statistical sensitivity and power, which could serve as better, more interpretable imaging biomarkers. This generically useful HCP-Style approach to measuring multi-modal non- invasive brain properties gives the neuroimaging field its best opportunity yet to understand the mechanisms that differ between healthy brain aging and Alzheimer’s Disease (AD) and Alzheimer’s Disease Related De- mentias (ADRD).